STAT4 regulation of Th17 pathogenicity

Project Summary/Abstract
Autoimmune and chronic inflammatory diseases are on the rise in the United States and world-wide. The
etiology of most autoimmune and chronic inflammatory diseases is not known; however it is proposed that a
combination of genetic and environmental factors influence disease susceptibility. Genome wide association
studies of multiple autoimmune and chronic inflammatory disorders have identified single nucleotide
polymorphisms in several immunologically relevant genes that are linked to disease susceptibility, including the
members of the IL-23/Th17 family and the human STAT4 gene. How STAT4 is coupled to the etiology of
autoimmune and chronic inflammation is not known, therefore it is imperative to understand the function of
STAT4 in the context of disease. The overarching hypothesis that STAT4 is a master regulator to IL-23
mediated chronic inflammatory and/or autoimmune disease by promoting the differentiation of
pathogenic Th17 cells and coordinately suppressing the emergence of anti-inflammatory Th17 cells.
The objective of this proposal is to:
Aim 1. To determine how STAT4 directs the accumulation of Th17 cells in inflamed peripheral tissues.
Aim 2. To determine if the STAT4/IL-10 axis in Th17 cells governs chronic inflammation.
Aim 3. To determine how STAT4 promotes pathogenic Th17 cell differentiation at the molecular level.

Public health relevance
PROJECT NARRATIVE CD4 T cells are central to the induction of numerous chronic inflammatory and autoimmune disorders, including Multiple Sclerosis and Inflammatory Bowel Diseases. Importantly, while the etiology of most autoimmune and chronic inflammatory disorders remains unknown, genome wide association studies as well as other research indicates a central role for IL-23 signaling, Th17 cells, and the transcription factor STAT4 in such diseases. This application will investigate the function of STAT4 during IL-23 dependent inflammatory diseases, with a focus on Th17 cells, to identify potential common underlying factors that promote disease.